Investigating Resistance and Resilience Mechanisms in Alzheimer’s Disease

PROJECT SUMMARY / ABSTRACT
Cognitive Aging and risk of Alzheimer's disease, and Alzheimer's related dementias (AD/ADRD) is due to
multiple aging and pathological processes that are driven by several upstream brain mechanisms and risk
factors. The success of recent multi-domain interventions and our preliminary data suggests that multiple
mechanisms need to be targeted for effective dementia prevention. In 2018, we proposed a simplistic conceptual
framework that builds on existing concepts using the nomenclature of resistance in the context of avoiding AD
pathology and resilience in the context of coping with AD pathology for investigating these distinct mechanisms.
This proposal addresses an important barrier for developing effective therapeutic or preventive strategies for AD
dementia - the poor understanding of how upstream risk factors and brain mechanisms (resistance and
resilience) that could contribute to or protect from protein accumulation and neurodegeneration. Our central
hypothesis is that identifying upstream brain mechanisms of resistance and resilience and modeling the complex
inter-relationships between protective factors, brain mechanisms, and longitudinal changes in amyloid, tau, and
cognition will aid in effective design of dementia prevention strategies.
To test this hypothesis, our primary aim is to identify mechanisms of resistance and resilience using the existing
infrastructure of the population-based Mayo Clinic Study of Aging (MCSA) (individuals aged ≥50 years) and
Rochester Epidemiology Project (REP) which maintains a comprehensive medical records-linkage system. We
will collect the following variables for this proposal: Genetics, Social Determinants of Health (SDoH), and
systemic health (up to 20 years prior to scan from REP), longitudinal PiB and tau PET, baseline cutting edge
MRI (high resolution T1/T2/FLAIR and multi-shell diffusion MRI to assess perivascular spaces, microstructural
integrity, and cortical thickness), and cognitive decline. Our secondary aim is to develop and validate MRI-
based resilience markers that can be used in the NIA-AA research framework alongside with AT(N) biomarkers
to adjust for individual variability in cognition. Considering brain health measures (other than those included in
the evaluation of N) as resilience markers will improve the prediction of cognitive decline across all aging and
dementia studies. These measures will be able to capture biological variability due to SDoH and systemic health
and facilitate better comparison of biomarkers across populations.

Public health relevance
PROJECT NARRATIVE While several research studies have demonstrated the positive impact of protective factors in Alzheimer's disease, this knowledge is yet to be translated into feasible dementia prevention trials. Understanding fundamental mechanisms through which important protective factors alter Alzheimer's disease trajectories is crucial to facilitate bench-to-bedside translation. In this proposal, we provide a theoretical framework to discover mechanisms that help prevent Alzheimer's disease pathologies or cope without cognitive symptoms even with Alzheimer's disease pathologies.